Military Parents’ Stress Exposure Associated with Mental and Behavioral Health Outcomes among Their Young Children

PROJECT SUMMARY/ABSTRACT:
Although many military families cope successfully with wartime military service, mounting empirical evidence
suggests that a sizeable subset of military-connected children may experience negative consequences, including
mental health problems, substance use, and suicidality. Prior research has demonstrated an association
between parental deployment and these outcomes, but military-specific stressors alone do not adequately
explain the risk for poor adjustment among nearly 2 million military-connected youth. This knowledge gap
suggests the need to examine a broader spectrum of psychosocial stressors to better explain adverse mental
and behavioral health outcomes in this vulnerable sub-population. The present study employs a novel, family-
level stress process lens to consider various mechanisms through which early, chronic, and recent non-military
stressors may combine with military stressors to influence the mental health of military parents and more
completely explain risk for adverse mental and behavioral health outcomes among young military-connected
children. We use secondary data from the Department of Defense’s (DoD) Millennium Cohort Family Study
(MCFS), a longitudinal survey of 9,872 married military couples. The MCFS project and linked archival DoD
datasets offer a unique opportunity to explore family-level stress processes, including stress proliferation, stress
sensitization, muting of psychosocial resources, and lateral proliferation of stress. Dyadic baseline data includes
measures of service member’s (SM) and spouses’ early, chronic, and recent non-military stressors (e.g.,
maltreatment in childhood, stress related to racial/ethnic minority status, and recent traumatic life events), military
stressors (e.g., deployment), psychosocial resources like coping, and mental health. Data collected at 3-year
follow-up include parent-reported and objective measures of child mental and behavioral health. Using structural
equation modeling, we will explore the dyadic effects of non-military and military stressors on the mental health
of each parent and their partner. Further, we will explore whether each parents’ early stress exposure and
psychosocial resources affect the relationship between recent stressors and their own and their partner’s mental
health. Finally, we will explore the relationship between parents’ stress exposure and children’s risk for poor
mental and behavioral health outcomes, considering the role of parents’ mental health as a mediator, as well as
differential effects for children of different ages and genders. Findings will lead to increased understanding of the
lateral proliferation of stress processes among members of a family system. Further, consistent with newer
approaches to health promotion, understanding these relationships will inform targeted prevention and
intervention efforts to reduce risk associated with exposure to toxic stress in young military children, support
healthy family functioning, and improve developmental outcomes for these youth and their families.

Public health relevance
PROJECT NARRATIVE: Though evidence has implicated the adverse effects of deployment, exposure to stressors related to parental military service do not adequately explain increased risk for poor outcomes among nearly 2 million US military children. This study explores how military parents’ exposure to a broad array of early, chronic, and recent military and non-military stressors may affect their mental health, the mental health of their partner, and ultimately the mental and behavioral health of their children. Findings will more precisely illuminate potential intergenerational pathways for transmission of stress and mental distress and inform targeted prevention and intervention efforts to reduce exposure to toxic stress specifically among young military children.